Advanced Genetic Engineering to Unravel Tumor-Specific B Cell Responses

RESEARCH SUMMARY
B cells are among the most abundant tumor-infiltrating immune cells, and their presence in several solid tumors
is associated with a more favorable prognosis. Yet, investigations on the role of B cells in cancer have so far
yielded contradicting results, with some studies indicating a tumor-promoting role and others suggesting
anticancer activity. In addition to their role in the production of antibodies, naturally occurring cancer-specific B
cells can directly participate in tumor suppression by i) direct killing of tumor cells via granzyme B, TRAIL, and
FasL expression and ii) by triggering robust T cell immunity, through activation of inflammatory responses and/or
through their professional antigen-presenting cell (APC) function. Indeed, tumor-infiltrating B cells often form
immune compartments called tertiary lymphoid structures (TLS), the presence of which in human tumors is
associated with a favorable response to immunotherapy. Preclinical studies have shown that adoptive transplant
of effector B cells collected from the tumor-draining lymph nodes (TDLN) of BC-bearing mice mediate the
reduction of lung metastases and trigger the establishment of tumor-specific T cell immunity. However, tumor-
specific B cells within TDLN are rare and difficult to specifically select and expand from the extensive polyclonal
repertoire of patient B cells. Here, we hypothesized that homology-driven gene editing could be exploited to
rapidly generate tumor-specific B cells that can be used to study the role of antigen-specific B cells in tumor
progression, with the ultimate goal of developing innovative immunotherapeutic strategies. We will exploit an
optimized B cell gene editing protocol we have recently developed to redirect the specificity of the endogenous
B cell receptor (BCR) towards the HER2 tumor-associated antigen. The efficacy and tolerability of this adoptive
immunotherapy strategy will be evaluated in vivo by exploiting both mouse models of breast tumors expressing
human HER2 and xenogeneic murine models of human cell transplantations. The bidirectional interaction of
transplanted B cells with immune cells of the tumor microenvironment will be investigated by single-cell
transcriptome analyses. Establishment of epitope spreading and T cell immunity will be assessed by measuring
tumor cytotoxicity and cytokine production of T cells harvested from the transplanted mice. If successful, this
novel precision medicine strategy will redirect both the humoral and cellular immunity against cancer, thus
introducing a new and powerful weapon to the oncologic therapeutic armamentarium and opening new avenues
for empowered cancer-adoptive immunotherapies.

Public health relevance
PROJECT NARRATIVE Tumor-infiltrating B-cells (TIBs) have been described in various solid tumors and constitute the 3rd most abundant tumor-infiltrating cells. TIBs often form immune compartments called tertiary lymphoid structures (TLS), where T-cells are activated through B-cell signaling and their professional antigen-presenting function. We hypothesized that gene editing could be exploited to redirect the specificity of the endogenous BCR toward the tumor antigens to study the role of antigen-specific B cell responses in tumors and ultimately develop novel immunotherapy strategies. The efficacy of this adoptive treatment will be evaluated in vivo in breast cancer mouse models. This in-vivo immunization strategy will redirect both the humoral and cellular immunity against solid tumors, introducing new avenues for empowered cancer-adoptive immunotherapies.